CORE--FLOW CYTOMETRY ANALYSIS

All of the Projects of this Program are very heavily dependent on analysis by flow cytometry. Three Becton-Dickenson instruments for this are available to the group. Funds are requested to support the maintenance and necessary repairs for these instruments to insure that they are available to investigators at all times.